Gap Junctional Patterning in the Arrhythmic Heart

PROJECT SUMMARY/ABSTRACT The unregulated opening of hemichannels (HCs) formed by the gap junction (GJ) protein Cx43 during myocardial infarction (MI) contributes injury spread, cardiac muscle loss and the formation of an arrhythmic substrate. In the previous period, we demonstrated that the Cx43 mimetic peptide αCT1 spares left ventricular muscle and contractile function in a mouse ischemia reperfusion (I/R) injury model and determined that the molecular mechanism of this 25 amino acid peptide’s cardioprotective activity was via binding to the H2 domain of Cx43. This interaction induces a cardioprotective Protein Kinase C phosphorylation of Cx43 at serine 368 (S368) — a post-translational modification known to reduce the activity of HCs. It was further shown that the main niche for HCs — the GJ perinexus — demonstrates high concentrations of Nav1.5/Scn5a voltage-gated sodium channels (VGSCs) and that the VGSC beta subunit β1/Scn1b maintains perinexal adhesion, enabling formation of trans-activating sodium channels that have key assignments in cardiac conduction and arrhythmia. The previous funding period also included completion and publication of results from two Phase II clinical trials on αCT1. In new preliminary data, we show that a short (9 amino acid) variant of αCT1, called αCT11: (1) Potently reduces ventricular infarct size by 48 % in an in vivo mouse model of MI, with significant preservation of echocardiographically-assessed contractile function when given post-ischemia; and (2) Preserves conduction and inhibits transition to discordant alternans in an ex vivo ischemia model. We have reported that like αCT1, the αCT11 mechanism is via Cx43 H2 binding and S368 phosphorylation. However, unlike αCT1 (which incorporates an antennapedia penetration sequence) our data indicates that the αCT11 reaches it cytoplasmic target, the Cx43 H2 domain, via permeating HCs. During the next funding period our aims are to: (1) Undertake rigorous testing of post-MI αCT11 efficacy in preserving cardiac muscle and preventing arrhythmias in vivo; (2) Determine whether αCT11’s mode-of-action involves the short peptide permeating HCs; and (3) Test a novel approach to loading of exosomes with αCT11 and undertake proof-of-principle testing of this formulation in preclinical models of MI. The significance of these aims are underpinned by: (1) αCT1 now being in Phase III testing on more than 500 patients; (2) That there is no clinical approach for cardioprotection post-MI; and (3) The growing evidence that Cx43 HC activation is key to other ischemia-related pathologies, including diabetic foot ulcers and cerebral stroke. The studies proposed herein will provide mechanistic understanding and lay the basis for translation of new drugs targeting HCs. It is our premise that this work is a necessary prelude to clinical testing of HC-targeting drugs in humans as muscle-sparing and anti-arrhythmic therapies in the critical hours following a heart attack.

Public health relevance
PROJECT NARRATIVE Ischemic heart disease is a leading cause of death in the US, and many of the deaths from this disease result from arrhythmias caused by muscle loss that occurs following a myocardial infarction. This loss of heart muscle can be made worse by clinical interventions such as angioplasty that restore blood flow following myocardial infarction. In this project, we will explore the function and potential pharmacology of Cx43 hemichannels as a therapeutic target in myocardial infarction and arrhythmia with a new research direction involving use of exosomes as drug delivery vehicles for novel peptides, targeting unregulated hemichannel activity during heart attack.